Understanding the Impact of Xenobiotic Metabolism on the Gut Microbiome and Resilience against Gastrointestinal Pathogens

Abstract
The gut microbiome plays a key role in maintaining intestinal homeostasis and serves as a critical barrier against
invading microorganisms through competition, chemical antagonism, and immune modulation. However,
external factors such as exposure to xenobiotics (including non-antibiotic drugs, pesticides, plasticizers) can
influence the resilience of the gut microbiome and its susceptibility to infections.
Recent studies have demonstrated the impact of xenobiotics on the gut microbiome, with increasing evidence
suggesting that non-antibiotic xenobiotic exposure can alter microbial composition, potentially facilitating
pathogen expansion. This is especially concerning for gastrointestinal pathogens such as Salmonella enterica
and Vibrio cholerae, where chemical pollution is often found as a confounding exposure factor. Although multiple
studies have shown the influence of xenobiotics on microbiome composition, there remains a major knowledge
gap in the mechanistic understanding of how these exposures shape microbial metabolism that controls
resilience to invading pathogens.
My research program aims to fill this gap by investigating how xenobiotics and their biotransformation products
affect the gut microbiome's composition, metabolism, specialized metabolite production, and ultimately resilience
against invading bacteria. Using a synthetic microbiome model and our functional metabolomics tools, we will
assess the inhibitory effects of xenobiotics, and their biotransformation products on commensal bacteria and
pathogens. Additionally, we will explore the long-term effects of xenobiotic exposure by evolving commensal
bacteria to investigate cross-resistance to antibiotics, and their impact on pathogen colonization. Ultimately,
these experiments aim to uncover mechanistic insights into bacterial antagonism under xenobiotic stress and
explore how adaptive responses within microbial communities influence the resilience towards invading
pathogens. Together, this project will provide new insights into how xenobiotic pressures shape microbial
ecosystems and pathogen resilience, with translational implications for future microbiome-based therapeutics.

Public health relevance
Project Narrative This project aims to determine whether non-antibiotic xenobiotics and their biotransformation products shift gut microbiome composition and alter specialized metabolite production. Beyond these fundamental mechanistic insights, I will investigate whether xenobiotic stress and induced resistance alter the resilience of commensal gut microbes against the colonization of Salmonella enterica and Vibrio cholerae.